ELASTICITY AND ACTIVE FORCE GENERATION IN COCHLEAR OUTER HAIR CELLS

To establish the magnitude of the electromechanical force generated by the outer hair cell from the mammalian cochlea, we use a cylindrical membrane model characterized by area and shear moduli for a passive elastic element, and a membrane potential-dependent, active tension-generating element. We measured pressure-strain relations to determine the elastic moduli, and found the area modulus was both close to a lipid bilayer and an order of magnitude larger than the shear modulus. We also determined that the active tension element is nearly isotropic, with an amplitude sensitivity of about 2x10~2 Nm~1VAt 73 dB of acoustical stimulation, the active force generated per outer hair cell is about 0.6 nN--close to the force applied to a corresponding area of the basilar membrane by acoustic pressure. This finding supports the hypothesis that the outer hair cell acts as a feedback motor in the fine-tuning mechanism of the mammalian ear.